Synergistic effect of APOE genotype and obesity in CNS inflammation and risk of Alzheimer's disease

PROJECT SUMMARY
We have previously pursued the hypothesis that APOE genotype alters normal brain neurochemistry and
structure early in life, generating an environment that alters the risk of Alzheimer’s Disease (AD) with aging.
Studies with APOE knock-in mice have demonstrated that APOE genotype affects neuroinflammation in
response to various neurological injuries in an isoform-specific manner, with apoE4 displaying the least anti-
inflammatory activity. Inflammation is also a consequence of several environmental risk factors for AD, such as
traumatic brain injury, obesity, and metabolic syndrome. Obesity is the strongest environmental risk factor for
AD. With 14% of the US population being APOE4 carriers and 35% of the population suffering from obesity, it is
extremely important to understand how these two common AD risk factors synergize. Sex is also a critical
variable in the risk of cognitive impairments, with females at significantly higher risk. Thus, the risk of AD depends
on a complex set of connections between genetic, environmental, and sex effects. This project aims to analyze
these interactions in healthy rodent models, thus providing early disease targets that could be use as markers
of AD risk and as targets for disease intervention. Aim 1 will determine robust markers of neuroinflammation in
APOE3 and APOE4 male and female mice after experiencing chronic peripheral inflammation induced by diet.
We will test our hypothesis that specific neuroinflammatory pathways will be coordinately affected by
these three AD risk factors. We have begun to identify neuroinflammatory pathways through non-directed
transcript analysis, and we will test the rigor of those findings through qPCR. We will further refine specific
neuroinflammatory pathways using immunofluorescence, in situ hybridization analyses, and kinase measures.
Finally, we will define inflammatory cell responses by defining the density, morphology, and motility of the
microglia using our model of CX3CR1GFP/+ mice on APOE3 and APOE4 knock-in backgrounds. Aim 2 will
determine the effects of two safe, anti-inflammatory drugs on CNS inflammation markers in the subgroups of
most affected APOE female and male mice. We will treat APOE3 and APOE4 mice on a high fat diet with
metformin (a diabetes treatment) or 4F peptide (promoting high density lipoproteins). We will test our
hypothesis that safe anti-inflammatory drugs could reduce the neuroinflammatory pathways most
consistent with AD risk factors. These studies will refine the pathways identified in Aim 1, and further those
findings by addressing whether there are functional CNS consequences of these treatments through behavioral
assays. Furthermore, we will test whether any inflammation pathways identified in CNS correlate with effects in
the blood using assays on plasma samples. By the end of this R21 study, we will have identified a subset of
neuroinflammatory molecules that could be use as early markers of AD risk and defined whether anti-
inflammatory approaches will be useful in personalized medicine approaches taking APOE genotype, diet, and
sex into account.

Public health relevance
PROJECT NARRATIVE APOE4 is the strongest genetic risk factor for Alzheimer’s disease (AD) and obesity is one of the strongest environmental risk factors for AD. These risk factors share effects on neuroinflammation, and this proposal will identify which inflammatory mechanisms in particular are affected in common. Using a mouse model, we will examine whether sex and APOE-related neuroinflammatory pathways exacerbated by diet can be used as biomarkers of AD risk and as targets for early disease intervention.